Social Confounders for Health Outcomes Linked to education

Project Summary / Abstract
The SCHOOL (Social Confounders for Health Outcomes Linked to Education) study will
utilize an existing sample and infrastructure from prior NICHD-funded studies (SAFE
[Study of Attitudes and Factors Effecting Infant Care Practices] and SMART [Social
Media and Risk Reduction Training for Infant Care Practices]) to identify factors that
mediate and moderate the impact of education on child health. Using our already
collected data, we have begun this work by identifying maternal attitudes and beliefs that
mediate the impact of education on whether mothers place their infants in the supine
position for sleep, thereby decreasing the risk of Sudden Infant Death Syndrome (SIDS)
and Sudden Unexpected Infant Death (SUID). For the SCHOOL Study, we will further
analyze these existing data and conduct qualitative research with SMART participants to
gain insight into additional factors that mediate the association between education and
child health. Further, we will develop a new comprehensive protocol and collect data
with SMART participants to illuminate specific pathways between education and child
health. Our Specific Aims are:
Aim 1: To determine the association between maternal education and children’s early
home experiences, including home resources, parental well-being, quality of family
relationships and parental child health care practices.
Aim 2: To determine the extent to which the association between parental education and
children’s health is mediated by children’s early home experiences, including home
resources, parental well-being, quality of family relationships and parental child health
care practices.
Aim 3: To determine the extent to which, after controlling for home experiences, the
association between parental education and children’s health is further mediated by
children’s participation in and quality of early education experiences.

Public health relevance
Project Narrative Our ability to utilize an existing prospectively obtained mother/infant birth cohort and the infrastructure we have established to continue to follow these families provides a unique opportunity to better understand the early childhood experiences underlying the associations between education and child health. Identification of these factors, some of which may be modifiable, can lead to targeted interventions to improve health outcomes across educational experiences and serve as a model for addressing health-related practices across age groups.